Horizontal gene transfer as the source of evolutionary innovation in eukaryotes

This is a supplemental equipment request to the project R01GM111917 in response to NOT-GM-24-021
to purchase a Biacore™ X100 system from Cytiva. This unique piece of equipment takes advantage of
the state-of-the-art technology (surface plasmon resonance) to monitor protein-RNA interactions within
a protein complex consisting of eight monomeric subunits, which is capable of non-templated RNA
tailing in vitro. We will be able to perform RNA binding assays and to determine whether the known
inhibitors of reverse transcriptases would also affect non-templated tailing by the studied group of
reverse transcriptase-like enzymes.

Public health relevance
With this supplemental request, we are seeking to acquire a benchtop instrument for analysis of interactions between proteins, nucleic acids and small molecules that would enhance our access to the new technology.